FOREBRAIN RESPONSES TO CHRONIC PAIN AND ITS TREATMENT

(Adapted from the Applicant's Description) Chronic pain due to disease or injury of the peripheral or central nervous system (chronic neuropathic pain or CNP) continues to present a serious obstacle for the psychological and social adjustment of persons with neurologic disabilities. The rehabilitation of these patients would improve if more was known about the cause of CNP and the frequent failure of CNP to respond to treatment. This Program Project is designed to advance the understanding of several factors that influence the development of CNP and its resistance to treatment in patients with spinal cord injury (SCI) and brachial plexus injury (BPI). The overall hypothesis is that CNP, and its resistance to treatment, is caused or maintained by a maladaptive reorganization of forebrain responses to somatic stimulation adjacent to the denervated region. Patients and normal control subjects will be recruited by the Clinical Core (Dr. Leonard) where clinical, psychological, and psychophysical evaluations and pain treatment protocols will be conducted. In project l (Dr. Minoshima), regional cerebral blood flow (rCBF) responses, indicative of synaptic activity, will be analyzed in patients and normal subjects receiving noxious and innocuous infra-red laser stimulation to each side of the neck (above the affective site in patients). Subtraction techniques across and within subjects will be used to identify pain and CNP-specific responses and response changes. The effect on these responses of treatment with a tricyclic antidepressant (TCA) will be determined. In project 2 (Dr. Beydoun), infra-red laser evoked potentials (LEPs) will be recorded from patients and normal subjects receiving laser stimulation of the hand, neck, and sites immediately adjacent to the denervation region. Principle components and dipole localization analyses will be used for 3 dimensional spatial and temporal localization of LEP components. Pain and CNP-specific LEP responses and response changes will be determined by subtraction methods and longitudinal comparisons of CNP developments within patients. The effect of TCS therapy on LEP components and laser psychophysical measures will be determined. In project 3 (Dr. Morrow), the development off specific patterns of the forebrain rCBF response to CNP and CA analgesia will be identified in the rat, using high resolution quantitative autoradiography and the chronic sciatic nerve ligature model of CNP. Behavioral measures of chronic and evoked nocifensive responses will be correlated with changes in the pattern of stimulus-evoked responses to noxious and innocuous somatic stimuli.